Dopaminergic mechanisms of resilience to Alzheimer's disease neuropathology

PROJECT SUMMARY
While the development of Alzheimer’s disease (AD)-related β-amyloid (Aβ) and tau pathology is associated
with declines in brain structure and cognitive function on a population level, there is considerable heterogeneity
in these effects across individuals. Individual differences in the brain’s dopamine system represent a
compelling moderator of Aβ and tau pathology’s effects on brain structure and function. Previous research has
established that an “optimal” genetic polymorphism presumed to increase dopamine D2 receptor affinity
(DRD2 C957T; rs6277) is associated with greater cortical thickness. While the mechanisms driving this effect
are not known, dopamine can be neurotrophic and D2 receptors mediate a number of neuroprotective
functions that may counteract AD processes including reduction of neuroinflammation. Relevant to the
successful maintenance of cognitive function despite pathology, higher D2 receptor availability is associated
with better executive function and memory. We propose the DRD2 T/T genotype supports resilience to AD-
related tau and Aβ pathology. Analyses will focus on cognitively normal and mild cognitive impairment groups
for which establishing the mechanisms of successful AD resilience are most relevant. We will use the
Alzheimer’s Disease Neuroimaging Initiative (ADNI) dataset to pursue the following Specific Aims. We will first
establish a role of the DRD2 T/T genotype in conferring greater cortical thickness despite Aβ
([18F]Florbetapir/Florbetaben) and tau ([18F]Flortaucipir PET) pathology cross-sectionally (Aim 1). Next, we will
investigate the role of DRD2 T/T genotype in cognitive reserve by probing genotype x pathology interactions in
cross-sectional and longitudinal measures of executive function and memory using the Preclinical Alzheimer
Cognition Composite. We will test the hypothesis that the T/T genotype is associated with better-than-expected
cognition given tau and Aβ burden (Aim 2). Finally, we will track longitudinal clinical decline using the Clinical
Dementia Scale – Sum of Boxes and longitudinal decline in cortical thickness to determine the extent to which
the T/T genotype predicts slower clinical decline and brain maintenance (Aim 3). The successful completion of
these aims will provide novel evidence that the dopamine system interacts with AD pathology to affect aging
trajectories, and will support therapeutic targeting of the dopamine system for individuals predisposed to lower
D2 affinity.

Public health relevance
PROJECT NARRATIVE Identifying the neural mechanisms underlying successful maintenance of brain structure and function despite neuropathology promises to shed light on targets for clinical intervention. Individual differences in dopamine D2 receptor function have been linked with individual differences in cortical thickness, executive function, and memory. The current proposal will investigate the extent to which “optimal” D2 genotypes confer resilience to Alzheimer’s disease pathology.